Neural organoid models of the immunological microenvironment of glioblastoma for drug discovery applications

Project Summary/Abstract
Glioblastoma (GBM) is the most prevalent primary brain tumor in adults with extremely poor
survival rates and largely unchanged standard of care. While there are many challenges to
developing better GBM treatments, one of the major challenges is the immune-suppressive
environment commonly found within GBM tumors. This immune-suppressive nature results in a
tumor that is not suitable for mounting an immune response to GBM cells, rendering emerging
immunotherapies ineffective. To address this issue, suitable models that can interrogate the
complex interactions between GBM cancer cells and microglia and peripherally derived
macrophages would be invaluable for target identification, screening of novel therapeutics and for
mode of action studies. Tumor-associated microglia and macrophages are of particular interest
due to their primary role in shaping the immunological environment of GBM tumors. Human
organoid technology is well-suited for modeling complex, multicellular interactions in a human
tissue-like environment. Stem Pharm’s hydrogel-enabled neural organoids allow for incorporation
of non-neural populations such as microglia and macrophages in a reproducible, 96-well plate
format amenable to screening applications. Therefore, work in this proposal will develop and
validate a human in vitro glioblastoma organoid model through incorporation of microglia,
macrophages, and patient derived GBM cells in our neural organoids. Specific aims will 1)
characterize organoids incorporating GBM, evaluate GBM survival, invasion, and proliferation;
and characterize cell-type specific transcriptional responses to GBM and compare them to parent
tumors and publicly available data sets. 2) demonstrate immunosuppressive activation of
microglia and macrophages within the neural organoid in response to infiltrating GBM cells.
Multiplex cytokine panels, co-stimulatory and checkpoint molecule expression, and a direct
immunosuppression assay with peripheral blood mononuclear cell-derived T-cells will be used to
evaluate microglia and macrophage immunosuppression. Finally, treatment with three small
molecules known to modulate macrophage activation will be assessed within the organoids to
demonstrate the ability to regulate the microglial and macrophage response to GBM cells.
Successful completion of these specific aims will result in a robust in vitro organoid model with
novel capabilities to interrogate GBM invasion and subsequent microglia and macrophage
immunosuppression. This will provide pharma partners with the ability to study therapies that
previously failed due to this immunosuppressive environment, and test new therapeutic
approaches. Phase II studies will expand the number of available patient-derived samples to
better capture the diversity and heterogeneity of GBM tumors, explore sex-linked differences, and
evaluate the effectiveness of CAR-Ts and combination therapies within the GBM model with the
goal of bringing better treatment options to patients for this devastating condition.

Public health relevance
This project will apply Stem Pharm’s human neural organoids for the development of glioblastoma models that are amenable to screening for drug discovery applications. Through inclusion of patient-derived glioblastoma cancer cells, microglia, and peripherally derived macrophages, we aim to develop a model that better represents the immunosuppressive environment of glioblastoma tumors for evaluating emerging therapeutics to eliminate cancers.